CORE A: ADMINISTRATION

SUMMARY – Administrative Core A
The overall goal of the Administrative Core is to create a vibrant, transparent, cohesive and diverse community
of skin investigators at Mount Sinai and beyond that synergizes to decrease research costs, exploit
technological advances, and elevate the level, speed, efficiency and innovation of research over what can be
achieved by individual investigators on their own. The Core will coordinate the outreach activities of the
SBDRC and its Resource Cores, ensuring that these benefit investigators broadly across the region. Its
programs will bring new investigators into skin research, support transition to independence for senior trainees
and junior faculty, and foster development of physician-scientists who can translate research findings to the
clinic. We will revamp approaches to recruitment, mentoring and retention of women and minority trainees and
faculty and enhance the pipeline of minority students entering skin research to ensure equal opportunities for
individuals of all genders and ethnic backgrounds and promote a diverse, creative and holistic approach to
research in skin biology and diseases. To achieve these objectives, we will establish an Executive Committee
that will, together with the Director and Associate Directors of the Center, provide overall management and
coordination of SBDRC activities, and ensure ethical and transparent administration and adherence to
regulatory guidelines. To optimize and continuously innovate our programs and services, we will regularly
survey the SBDRC community and establish Internal and External Advisory Committees to provide feedback
on programs and services. We will communicate with our members and with the larger research and lay
communities through a Website, social media, a monthly Bulletin and a semiannual Newsletter. We will hold an
informal Faculty Forum, regular Work in Progress talks, and Resource Core Seminars to share ideas and data,
and disseminate information about Core services and technical innovations. Research Seminars from internal
and external speakers and an Annual Retreat will stimulate collaborations and keep the Community informed
of the latest discoveries. To decrease the costs of high-end technologies, we will provide User Scholarships for
projects of high scientific merit, and Pilot Grant funding for junior investigators and those newly entering the
field. Mentoring Committees will be organized to help post-doctoral fellows and research-oriented dermatology
residents transition to independence, and support success for junior faculty. To improve diversity of our
Community, we will advertise trainee and faculty positions to a more diverse applicant pool and re-assess
evaluation metrics. To enhance the pipeline of minority students entering skin research, we will establish the
SBDRC Sinai Skin Scholars Program, which will provide local underserved high school students with teaching
and hands on laboratory experience in skin biology and diseases research. Together these programs will
provide synergy and structure for our Research Community and promote innovation and discovery.